Nanotherapeutic enhancement of interstitial thermal therapy for glioblastoma

Project Summary
Brain invasion, limited drug delivery, and treatment resistance render glioblastoma (GBM) virtually untreatable
with current surgical, chemo- and radiation therapy approaches. Tumor recurrence is nearly universal, and the
median patient survival (~15 months) has not changed significantly in 20 years. Radical new ideas and
approaches are needed to change the course of this devastating disease.
New neurosurgical approaches to treating GBM are emerging with the FDA approval of minimally invasive
and image-guided technologies that now enable access to and treatment of previously unresectable and complex
recurrent tumors. A major advance has been the development of magnetic resonance imaging (MRI)-guided and
monitored, robotically controlled laser probes for intra-tumoral thermal treatments (e.g., laser interstitial thermal
therapy [LITT]). LITT is increasingly used to treat deep-seated, unresectable tumors through both direct thermal
ablation and priming to sensitize the tumor to radiation. Such thermal priming of solid tumors, including GBM,
has been known for decades to increase the efficacy of radiation treatment. However, tools to safely and
effectively accomplish this in neurosurgery have been lacking. Our clinical research team is leading two Phase
I trials (NCT04181684, NCT04699773) investigating LITT-based priming of GBM for enhanced radiation. While
the preliminary results in GBM patients have been promising, many patients (~40%) experience usually
temporary adverse effects, such as brain edema and seizures. We predict that improving the heat transfer within
the tumor and reducing thermal effects on surrounding brain tissues will reduce side effects and accelerate the
clinical translation and efficacy of this new approach.
Gold nanoparticle (AuNP)-enhanced photothermal ablation can increase thermal conductance and
capacitance within the tumor and reduce heat transfer to surrounding normal tissues. Combining AuNPs and
LITT offers the opportunity to improve the efficacy and safety of LITT. Our multidisciplinary team of experts in
surgical neuro-oncology (Woodworth), DART nanotechnology (Kim), GBM Fn14 biology (Winkles), and
plasmonic nanoparticles for photothermal therapy (Huang), is developing an advanced local drug delivery
strategy that bypasses the blood-brain barrier and leverages a novel Decreased nonspecific-Adhesivity,
Receptor-Targeted (DART) NP formulation. We have shown that DART nanoparticles, targeted to the tumor
necrosis factor receptor superfamily member fibroblast growth factor-inducible 14 (Fn14), can penetrate tumor
tissues to provide more uniform dispersion and selectively bind to and enter GBM cells, including those in the
invasive margin. The central hypothesis is that controlled, monitored intratumoral delivery of Fn14-targeted
DART AuNPs will significantly enhance LITT for GBM with fewer side effects on surrounding brain tissues. We
will test this hypothesis in Fn14+ or Fn14- GBM patient-derived xenograft (PDX) models using immunodeficient
rats and in an RCAS/tv-a-based transgenic rat model of Fn14+ human GBM.

Public health relevance
Project Narrative The brain cancer, glioblastoma (GBM), is among the most heterogeneous, treatment resistant, and lethal of all human cancers. The complexity of GBM and our slow progress in effectively treating this disease warrant new combination treatment strategies that leverage tools and technologies earlier in the disease management and during the time of surgical intervention. Here, we propose to test a combination intra-operative, image-guided treatment regimen where we use targeted gold nanoparticles to improve laser interstitial thermal therapy for GBM.